Defining cell-intrinsic trophoblast defenses to HCMV infection

PROJECT SUMMARY/ABSTRACT:
Human cytomegalovirus (HCMV) infection is among the most common congenital infections, occurring in
approximately 1 out of every 200 pregnancies. Congenital HCMV infection can lead to a wide range of
developmental complications including intrauterine growth restriction, sensorineural hearing loss, microcephaly,
and fetal demise. To infect and directly damage the developing fetus, HCMV must cross the placenta, which is
the primary barrier between maternal and fetal circulation. HCMV infection has also been proposed to impair
several critical functions of trophoblasts, the predominant cell type of the placenta, suggesting HCMV infection
could indirectly damage the fetus through placental dysfunction. However, due to limited models of HCMV
infection at the maternal-fetal interface we currently have an incomplete understanding of 1) how trophoblasts
defend against HCMV and 2) how HCMV infection alters normal trophoblast function.
I propose to use trophoblast organoids (TOs) to model HCMV infection. TOs are a novel model that recapitulates
many key aspects of the cellular and immunological complexity of the human placenta. Our lab has reported that
TOs are refractory to HCMV replication. My preliminary data demonstrate that this occurs post-viral entry,
signifying that trophoblasts may express cell-intrinsic factors that restrict HCMV replication. I have preliminarily
identified that the transcription factor DUX4 and its target gene TRIM43 (a recently described herpesvirus
restriction factor) are uniquely induced following HCMV infection in TOs, suggesting this pathway may contribute
to trophoblast resistance to HCMV replication. Aberrant expression of DUX4 in adult muscle cells alters normal
cellular function and drives pathology in facioscapulohumeral muscular dystrophy. My preliminary data suggest
that DUX4 expression in trophoblasts may similarly impair normal trophoblast function. The objectives of this
proposal are to identify factors that restrict HCMV replication in trophoblasts, uncover the impacts of HCMV
infection on normal trophoblast function, and build upon TOs as a model of HCMV infection at the maternal-fetal
interface. The specific aims of this proposal are 1) to determine if TRIM43 and DUX4 restrict HCMV
replication in TOs and 2) define the impacts of HCMV-induced DUX4 expression on trophoblast function.
Aim 1 will define the expression kinetics of TRIM43 and DUX4 in TOs following HCMV infection. It will then test
whether TRIM43 and DUX4 restrict HCMV replication in TOs. Finally, this aim will test whether TRIM43 and
DUX4 restrict the replication of other teratogenic herpesviruses in TOs. Aim 2 will map the trophoblast cell type-
specific transcriptional response to DUX4 expression to define potential mechanisms by which HCMV can cause
dysfunction in trophoblasts. Aim 2 will test whether HCMV-induced DUX4 expression impairs trophoblast
differentiation as well as key functions of trophoblasts such as hormone secretion and invasion. Completing the
proposed aims will provide training in several key areas, better equipping me to progress towards independence
as a scientist.

Public health relevance
PROJECT NARRATIVE: Human cytomegalovirus is among the most common congenital infections and can cause severe, lifelong symptoms for a developing fetus. In this proposal, I aim to elucidate how placental trophoblast cells defend against HCMV infection and how these defenses could in turn drive placental dysfunction. Studies such as this are critical to understand how viruses and other pathogens can cross the placenta, gain access to the fetus, and ultimately cause congenital disease.